Deciphering molecular mechanisms of Epithelial Plasticity

Project Summary/Abstract
Cellular plasticity, a feature associated with epithelial-to-mesenchymal transition (EMT), contributes to
tumor cell survival, migration, invasion, and therapy resistance. Across human cancer, tumors that are high
grade, poorly differentiated, and have undergone EMT carry a worse prognosis with a high likelihood of
metastasizing to distant organs. EMT is a common feature associated with tumor progression and is thought
to be critical to cancer cell dissemination in some tumors. Despite significant evidence that EMT directly
contributes to tumor progression, several studies have suggested EMT is not required for the metastatic
spread of PDA and breast cancer. For example, most metastatic lesions are known to exhibit epithelial
features, an observation that seems to be at odds with EMT as a prerequisite for metastasis. As such, the
importance of EMT in cancer biology has been questioned. I hypothesize that the chronic activation of an
EMT program within a tumor may depend on paracrine signals within the tumor microenvironment, dictating
whether the tumor cells undergo EMT or MET. Because these cells exist in a plastic state, it is possible that
these tumor cells readily revert their phenotype based on a microenvironment-specific context and factors.
Additionally, current in vivo lineage-tracing technology has not settled the debate between the importance
of collective migration and/or EMT for metastatic dissemination. During my postdoctoral research, I aim to
investigate this hypothesis in two aims: 1) Decipher genetic changes required for cellular plasticity
using a novel patient-derived organoid lineage tracing model, live-imaging and single cell analyses. 2)
Investigate extracellular cues for cellular plasticity and EMT by evaluating the role of the immune
system in EMT and metastasis. These aims will allow the field to better understand epithelial plasticity in
an oncogene- and tissue-specific manner. Understanding this process will aid in the development of
effective metastatic cancer therapies and will direct future research directions in metastasis.

Public health relevance
Project Narrative Despite significant research efforts, the function of EMT in metastasis has yet to be fully elucidated and metastatic cancers and relapse remain the primary cause of cancer related deaths. Using a novel patient- derived organoid lineage tracing system, live-cell imaging, and single cell analyses, I aim to investigate the contribution of EMT to metastasis in metastatic renal cell carcinoma as well as mechanisms underlying epithelial plasticity. Understanding this process further will aid in the development of effective metastatic cancer therapies and will direct future research directions in metastasis research.